Sleep Apnea-Specific Nocturnal Blood Pressure Surge to Determine Cardiovascular Risks and Therapeutic Benefits in Patients with Obstructive Sleep Apnea

Abstract
Obstructive sleep apnea (OSA) is a common sleep disorder associated with an increased risk of cardiovascular
(CV) disease. However, it remains uncertain whether treatment of OSA improves CV outcomes given the lack
of evidence from recent clinical trials. We hypothesize that characterizing repetitive nighttime blood pressure
(BP) surges following sleep apnea events improves risk stratification in OSA and helps identify those who benefit
most from therapy. OSA is a major risk factor for nocturnal hypertension, a well-established prognostic marker
for adverse CV outcomes, including mortality. Therefore, it is plausible that nocturnal hypertension acts as a
mediator between OSA and CV morbidity and mortality. However, continuous BP is not currently quantified in
clinical sleep studies for OSA evaluation, while the conventional ambulatory BP monitoring device that
intermittently measures BP is unable to capture BP surges associated with sleep apnea events. To capture sleep
apnea-specific episodic BP increase, we will use a recently validated finger-cuff-based beat-to-beat BP device
to monitor nocturnal BP during polysomnography (PSG). In this time-sensitive ancillary study, we propose to
examine the extent to which sleep apnea-specific BP increase is associated with an increased risk for CV
outcomes (Aim 1, cross-sectional study); and whether individuals with higher sleep apnea-specific BP surges
respond more favorably to continuous positive airway pressure (CPAP) therapy in terms of reduction in CV risks
(Aim 2, prospective study). In addition, we will examine the race-specific differences between White and African
American in the degree of sleep apnea-specific BP increase and whether the associations examined in Aims 1
and 2 are modified by race (Aim 3). To achieve these aims, we will leverage the infrastructure and resources of
the ongoing NHLBI sponsored parent study at the Brigham and Women's Hospital (N~160) in which novel PSG-
derived physiological metrics are being investigated to evaluate their utilities for predicting CV responses to 12-
week CPAP therapy in people with OSA. We will add continuous beat-to-beat BP monitoring to PSG recording
performed at the baseline study of the parent study. The primary CV outcome will be left ventricular strain by
speckle tracking echocardiography, which is a sensitive marker for subclinical mechanical left ventricular
dysfunction. Secondary CV outcomes will include other conventional echocardiographic measures of structural
and functional remodeling, electrocardiographic marker of left atrial electrical remodeling and arterial stiffness
by pulse wave velocity. We will also recruit additional African Americans to have sufficient statistical power in
Aim 3. The major innovation of this proposal is the incorporation of the continuously measured nocturnal BP and
other PSG-derived physiological measurements into the clinical decision making. Our study design allows for
race-specific investigation with the goal of better understanding the mechanisms linking OSA to the existing CV
health disparity in African Americans.

Public health relevance
Project Narrative Currently used conventional metrics for sleep apnea assessment has many limitations including insufficient consideration of acute cardiovascular response to sleep apnea event. We propose to study whether the degree of acute blood pressure elevation associated with sleep apnea can help better identify people with higher cardiovascular risk and a more favorable response to therapy. We will also investigate whether there is a racial difference in the degree of blood pressure elevation, which may explain cardiovascular health disparity in African Americans.